Task Order 2: The Interventional Agent Development Services Program

This task provides for lead identification, development, chemistry and synthesis services under the NIAID Preclinical Services for the Development of Interventional Agents Program for infectious diseases.